Uncovering mechanisms of pancreatic adaptability to weight cycling

Project Summary
Obesity is a risk factor for the development of insulin resistance (IR), a hallmark of type 2 diabetes (T2D). Weight
loss improves obesity-evoked IR; however, the majority of individuals who lose weight, regain the weight within
1-5 years. This ‘weight cycling’ further increases risk of metabolic disease compared to weight maintenance. Our
group developed a mouse model of weight cycling to uncover mechanisms by which weight regain poses
additional risk of metabolic disease. We show that weight cycled diet-induced obese (WC-DIO) animals have
worsened glucose tolerance than equally obese mice that have not weight cycled. A unique finding is that glucose
intolerance in WC-DIO mice is linked to impaired insulin secretion (in vivo during a hyperglycemic clamp and ex
vivo in perifused islets). This key finding indicates that β-cell compensation fails to completely adapt to the
physiological IR evoked by weight regain in the same way it does during the first bout of weight gain. At the
cellular level, WC-DIO mice manifest with atypical β-cell mitochondrial morphology and decreases in gene
signatures linked with mitophagy, redox metabolism, and TCA cycle regulation. Mitochondrial metabolism is
fundamental for normal nutrient stimulated insulin secretion. Thus, the mitochondrial alterations evoked by
weight cycling support a mechanism for impaired insulin secretion. Poor functioning mitochondria are also linked
with disruptions to redox control, which can increase oxidative stress and impair β-cell function. We find that a
major regulator of pro-oxidant status in β-cells, thioredoxin interacting protein (TXNIP), is increased in WC-DIO
islets and inversely associates with insulin secretion. Together, these preliminary studies support that in
response to repeated nutrient overload, β-cells are less efficient at coupling metabolic processes to insulin
secretion. The central hypothesis is that repeated nutrient overload decreases mitochondrial function and evokes
oxidative impairment in β-cells. This loss of β-cell adaptation to nutrient overload impairs insulin secretion and in
vivo glucose regulation. This proposal will: i) determine whether impaired mitochondrial function evoked by
repeated nutrient excess is central to loss of pancreatic function and ii) examine whether TXNIP is responsible
for driving oxidative stress and loss of pancreatic function with weight cycling. Stable isotopes will be used to
measure metabolic flux rates in isolated islets. 13C-labeled metabolites will be administered in vivo and
incorporation in β-cells quantified using imaging mass spectrometry. Pharmacological inhibition and β-cell
specific deletion of TXNIP will be used to determine whether attenuation of oxidative stress restores insulin
production and secretion. In vivo insulin secretion and insulin sensitivity will be determined using the frequently-
sampled intravenous glucose tolerance test coupled with glucose tracers to quantify glucose fluxes. Ex vivo islet
function will be determined in static culture and in perifusion assays. The experiments proposed herein will define
the means by which weight cycling uncouples peripheral IR from pancreatic insulin demand, which will lead to a
better understanding of the underlying mechanisms of pancreatic adaptability to excess nutrients.

Public health relevance
Project Narrative Diabetes is a complex disease that is defined by poor control of blood sugar. Loss of blood sugar control is related to a poor functioning pancreas, which is worsened in individuals who yo-yo diet, or weight cycle. The goal of this project is to identify the mechanisms of how body weight fluctuations evoked by weight cycling worsen pancreatic function and blood sugar control.